Develop and Evaluate a Targeted Education Campaign in Northern Manhattan and the South Bronx to Protect West African, South Asian, and Latinx Populations from Hazardous Skin Lightening Products.

Project Summary (30 lines of text):
The proposed project seeks to develop evidence-based education materials and culturally-specific
dissemination strategies in order to increase awareness on the use of and potential risks from skin lightening
products among vulnerable and underserved communities. Our proposal is relevant to the FDA’s mission of
protecting public health and ensuring the safety of cosmetic products, and to the FDA Office of Minority Health
and Health Equity’s (OMHHE) commitment to promote and protect the health of diverse populations through
research and communication of science that addresses health disparities. The project will develop and test a
community-based educational intervention targeting South Asian, West African and Latinx populations in
Northern Manhattan and the South Bronx. It will be designed to increase awareness about: (1) health risks of
hydroquinone, mercury, and other substances commonly found in skin lighteners; (2) upstream social and
cultural drivers of skin lightening use, including colorism; (3) strategies for individual and collective action to
avoid toxic exposures and ensure safer beauty products. The aims of the educational intervention and
subsequent evaluation are consistent with the aims of the FOA, to: (1) better understand public perceptions
about skin lightening products, through discussions with CBOs and participant surveys, (2) identify and provide
information needed for individuals to make informed decisions and/or take action, in terms of reading labels,
avoiding dangerous products, and reporting banned products to authorities including the FDA, (3) and develop
key messages for communications, though the development of a culturally appropriate educational module.
Our core team and partners, with decades of combined experience engaging with disadvantaged and
underserved communities on issues of toxic exposures and toxic cosmetics, including skin lighteners, are
well-suited to engage with communities and to develop, evaluate, and subsequently refine messaging
designed to inform and protect women from toxic skin lightening products. We will achieve these aims through
the following Aims: (1) Develop an educational module, based on the format of WE ACT’s existing
Environmental Health and Justice Leadership Training program (EHJLT), designed to provide community
members with strategies to recognize banned skin lightener products and avoid them as well as to take action
to report them; (2) Develop a train-the-trainer guide to supplement the EHJLT module, and conduct a
train-the-trainer process with staff members at three selected community groups serving South Asian, West
African and Latinx populations in Northern Manhattan and the South Bronx (with materials translated
appropriately for all three groups); (3) Deliver the module via the newly trained CBO staff to about 20
participants drawn from each CBO’s grassroots constituency (60 participants total); (4) Evaluate the
effectiveness of the intervention; (5) Revise the intervention in response to participant feedback, and
disseminate the module and our findings via a report and a dedicated landing page on the WE ACT website.

Public health relevance
Project Narrative: This project will provide research of urgent relevance to public health, and especially to the health of vulnerable and underserved communities, by informing public health educators on the most efficient way to raise awareness about the dangers of skin lighteners. With recent federal action effectively eliminating hydroquinone in over the counter (OTC) products, and with data supporting potential for exposures to other harmful chemicals, it is of urgent importance to develop, test, and identify effective messaging that informs BIPOC women in disadvantaged communities about the potential dangers of products being marketed to them as skin lighteners. By creating, administering, and evaluating an educational module on skin lighteners that can be distributed among community-based organizations, this project will protect women, especially women and girls in windows of susceptibility, from toxic exposures that can affect their long-term health and that of their children.